Prolyl hydroxylase oxygen sensor in Heart

DESCRIPTION (provided by applicant) The mechanisms that allow cells to sense and respond to oxygen (O2) are of fundamental importance in understanding how environmental factors impact upon a myriad of physiological, pathological, and developmental processes. Recently the cellular O2-sensor/transducing mechanism has been identified as a family of O2-dependent prolyl hydroxylase enzymes (PHD). In hypoxic conditions the hydroxylase activity of these enzymes are inhibited. The failure to hydroxylate hypoxia-inducible factor-l alpha leads to its accumulation. The cardiovascular system displays exquisite sensitivity to O2 with a characteristic constellation of both acute and chronic responses. Thus, the candidate proposes using the heart cell as a model system to explore the specific mechanisms that are affected by this O2-sensing pathway. New data by the candidate suggests that the PHD oxygen sensor may play a large role in the pathophysiology of the heart. Specific inhibitors of PHD activate the cellular hypoxic response, and lead to induction of two stress-response proteins; nitric oxide synthase-2 (NOS-2) and heme oxygenase-1 (HO-l). The overall goal of this proposal is to begin to explore consequences of the PHD-pathway activation and the nature of its role in the cellular response to hypoxic stress. The goal of Specific Aim 1 is to validate the use of PHD inhibitors as model agents. Neonatal myocyte cultures will be used to examine chronic PHD-pathway activation in order to evaluate if cellular responses to chronic hypoxia are recapitulated by PHD inhibitors. Specific Aim 2 capitalizes on the finding that NOS-2 protein expression is highly induced by PHD-pathway activation. The goal of this aim is to understand how PHD inhibitors lead to NOS-2 induction. NOS-2 expression will be evaluated at the transcriptional level with promoter analysis. Possible regulation of NOS-2 at the mRNA level will also be addressed by these studies. The most prominent acute response of the heart to hypoxia is a down regulation of contractility. The goal of Specific Aim 3 is to critically examine the notion that the PHD oxygen sensor plays a role in mediating the acute contractile dysfunction that is seen with ischemic or hypoxic insult.